Administrative Core

Project Summary – Administrative Core
The overall objective of the new UC Davis CounterACT Center of Excellence is to identify and advance the
development of therapeutic strategies for mitigating long-term, adverse neurologic consequences in individuals
who survive the cholinergic crisis triggered by acute intoxication with organophosphate (OP) cholinesterase
inhibitors. The Center is comprised of three scientific Projects, three scientific Cores, a Research Education
Core, an Emerging Science and Scientists Pilot Project Program, and multiple committees — all of which will
work closely together to ensure success. The Administrative Core will centralize coordination, communication
and integration among the Projects and Cores and foster synergy across the Center, ultimately ensuring the
Center meets annual milestones established in collaboration with NIH CounterACT program officer(s). Activities
will include providing overall scientific leadership, fiscal oversight, and logistical support as well as assistance
with disseminating research findings and encouraging and facilitating data sharing with external investigators.
Additionally, the Administrative Core will coordinate Center interactions with the UC Davis administration and
external entities, such as the NIH CounterACT administration, the Center’s External Advisory Board, the larger
CounterACT research community, the U.S. Food and Drug Administration (FDA), the Biomedical Advanced
Research and Development Authority (BARDA), and potential commercial partners. The Core’s objectives are
to: (1) Provide scientific leadership and logistics support to coordinate and integrate Center activities and
promote interactions among Center investigators to meet annual Center milestones; (2) Administer the Emerging
Science and Scientists Pilot Project Program (ESSP3); (3) Facilitate data and resource sharing among Center
investigators and other CounterACT investigators; (4) Provide budgetary oversight and grant management; (5)
Ensure the safety and security of personnel, materials, data and facilities; (6) Pursue intellectual property (IP)
strategies, and identify, engage and coordinate communications with commercial partners; and (7) Coordinate
with FDA, BARDA and other federal government agencies.